CLINICAL TRIAL: THE ROLE OF VISCERAL ADIPOSE TISSUE IN INFLAMMATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to understand the effects of body fat, particularly fat locked within the abdomen, on metabolism. Patients who are scheduled to undergo surgery, will be consented to donate a sample of their abdominal fat (omental adipose tissue), a small amount of abdominal wall muscle, and some of the fluid in their belly. We are interested in ways in which abdominal fat can mimic the immune system in causing inflammation.